CARDIAC ARRHYTHMIA SUPPRESSION TRIAL

The purpose of this study is to determine whether antiarrhythmic drug therapy results in a reduction in sudden arrhythmic death in patients with a recent (less than 90 days) myocardial infarction.